Career Development CORE

The mission of the Career Development Project is [unreadable] to develop future leaders in the environmental health sciences by developing early career scientists, and [unreadable] to support investigators who will integrate human studies into environmental health science.